Project-002

Engaging stakeholders through our outreach, research, and training programs has been the highest priority of
our CTSA Hub. These efforts increase the capacity for communication between researchers and
stakeholders, allowing us to advance the science of community-engaged translational research and build upon
our programs in multidisciplinary team-based science. Since 2008, we have focused on advancing team
science by developing, testing, and implementing leadership training for scientific teams, and by supporting
Multidisciplinary Translational Teams (MTTs) which bring together investigators from diverse disciplines who
are working along the translational spectrum to address priority health issues. Our broad-based
stakeholders include our leadership, investigators, patients, clinicians, advocacy groups, community
members and organizations, sister CTSA hubs, consumers of translational research and health information,
commercial interests, and policymakers. Our long-term objective is to integrate community engagement and
team-based science across the spectrum of translational science—in leadership and governance,
communications, implementation, research, and dissemination. Engaging patients and communities
throughout the translational research lifecycle and process enables us to ensure successful outcomes
through patient-focused research design, implementation, and dissemination. In past years, our programming
has focused on the Houston-Galveston metroplex and, in conjunction with the Texas Regional CTSA
Consortium, the other major cities in the state of Texas, i.e., San Antonio, Dallas, and Austin. In the coming
cycle, we will be actively increasing scientific and community collaborations with network partners including
NCATs and “ECHO” hubs, as well as other NIH Institutes and Centers, federal agencies, and industry. Our
Specific Aims include: Aim 1. Engage internal, external, and interdependent stakeholders at local, regional, and
national levels to make clinical research at all phases across the lifespan and translational spectrum more
responsive to and effective in meeting societal needs for the advancement of science and medicine. We will do
this by: promoting new multi-directional communication strategies to engage stakeholders across the
translational spectrum, establishing innovative avenues for translating and disseminating relevant science
and health information to stakeholders, and advancing the field of community engagement and at regional
and national levels; Aim 2. Promote advances in multidisciplinary team science methods, education, best
practices, and dissemination to drive significant advances in clinical and translational research by
disseminating our portfolio of Team Science Programs involving foundational skills and leadership training to
the CTSA consortium. We will also develop community partners’ and patient constituents’ modules for our
TeamMAPPS Project to promote inclusion of community members and patients in the development and
management of translational teams.